PhysioSim: Innovative Physiology Simulation Education Kits for Pre-College Students and Teachers

Project Summary/Abstract
The proposed project will create an innovative interactive physiology simulation product for use by pre-college
students to expose students to the health-science field and promote health-science-related careers.
Significance: The majority of the fastest-growing occupations are in health-related fields, and it is vital for the
US to train a workforce to meet those needs. There are many products and afterschool programs that support
STEM learning for high school students in the fields of robotics and engineering, but few that focus on health,
healthcare, and human biology. Finding avenues for students to experience the clinical relevance of physiology
“in action” may help student engagement, enthusiasm, and learning of physiology as well as help guide
biomedical career choices. Hypothesis: We hypothesize that adapting medical simulation technologies into
learning tools appropriate and cost-effective for use within precollege classes would be met with high
enthusiasm, overcoming both the cost and access barriers of traditional medical simulation products. Specific
Aims: In this Direct to Phase II project IDL and its team will: 1) Create a production-ready and student-friendly
system; 2) Develop a comprehensive curriculum and series of classroom activities; and 3) Evaluate the system
with a study of end-users.

Public health relevance
Project Narrative Evidence shows that activities promoting active learning rather than passive lectures improve students’ pursuit and persistence in STEM careers – most significantly for underrepresented students. While the introduction of STEM educational products has been working to increase the number of students pursuing careers in science, technology, engineering, and math, the health science area has been underserved. A product that provides students with hands-on activities and experience in health science-related fields may increase interest and the belief that they can successfully pursue healthcare-related careers.